Developing a Tailored Psychosocial Education Intervention for Chronic Pain Management for Asian Americans in the Community

PROJECT SUMMARY/ABSTRACT
Health inequalities in chronic pain exists in the US, with a greater burden of chronic pain and higher rate of
misdiagnosis and undertreatment reported in minoritized groups compared to non-Hispanic Whites. Asian
Americans (AA) are the fastest-growing racial/ethnic group in the US, yet despite the rapid growth in their
numbers, AA remain under-represented in pain disparity research. People from culturally and linguistically
diverse communities are known to have higher levels of pain, disability, and psychological distress when they
live in a Western environment. AA are linguistically diverse and among the racial groups most likely to be
limited in English proficiency, which may contribute to their linguistic and social isolation. Underdiagnosis and
underreporting of pain among AA have been reported. Cultural norms of Asians may discourage reporting their
pain to avoid burdening others or being seen as weak. Rather than seeking medical assistance, Asians have
been reported to tend to accept the pain as natural or to suffer to maintain their independence. Our preliminary
studies found that Korean Americans (KA) exhibited higher levels of pain severity and pain catastrophizing
compared to their counterparts living in Korea. However, very few evidence-based programs are available that
can be implemented for this linguistically/socially isolated population in the US. This proposed study aims to fill
critical knowledge gaps in pain disparity research by providing evidence of feasibility and acceptability of a
culturally-tailored psychosocial pain education intervention for an underrepresented population using the KA
community as an exemplar. Using a sequential exploratory mixed-method design incorporating a Community-
Based Participatory Research approach, we will: (1) iteratively adapt and culturally-integrate a previously
established psychosocial education intervention for KA to develop an effective program to improve pain
outcomes for underserved KAs with chronic pain in the community; conduct KA Community Advisory Board
meetings and participant focus group interviews to improve the intervention design, content, and cultural
relevance, and (2) evaluate the feasibility and acceptability of the culturally adapted psychosocial education
intervention using a single group, pre-posttest design with 30 foreign-born Korean immigrants with chronic pain
dwelling in the community. We will conduct a survey to assess improvements in the outcomes (i.e., pain
catastrophizing, pain intensity/interference) at 3 time points (pre-test, post-test, 12 weeks after the
intervention). Post-intervention in-depth interviews will be conducted with subset of the participants (n = 10) on
their reflections about the program. Feasibility and acceptability will be evaluated by integrating quantitative
(i.e., recruitment/retention rate, participants engagement) and qualitative (i.e., perceived appropriateness)
findings. Achievement of study goals will demonstrate for the first time that a nurse-led, community-based
psychosocial education intervention to reduce chronic pain for the underrepresented KA population may be
feasible and acceptable, forming the basis for a larger efficacy trial to test the tailored intervention.

Public health relevance
Chronic pain is a major population health issue affecting more than 100 million Americans and variations in chronic pain experiences have been widely documented, including differences in pain burden and likelihood of undertreatment. Evidence regarding chronic pain experiences of Asian Americans is limited, as are resources and evidence-based programs for this group. Our exploratory, developmental study will provide evidence of feasibility and acceptability of a tailored psychosocial education intervention to reduce pain catastrophizing and improve pain outcomes for Asian Americans.